Radiotracer-Based Imaging for Quantitative Assessment of Skeletal Muscle Perfusion in Peripheral Artery Disease

PROJECT SUMMARY
Patients with lower extremity peripheral artery disease (PAD) are at increased risk of lifestyle limiting
claudication, ulceration, amputation, and death. Despite this knowledge, an ongoing challenge for the vascular
community is the lack of a standard non-invasive test for quantifying regional abnormalities in skeletal muscle
perfusion in PAD. Our laboratory has been at the forefront of translating nuclear perfusion imaging techniques
to patients with PAD and demonstrated the potential prognostic value of these methods for prediciting clinical
outcomes. Specifically, in the prior funding period of this award, we clinically translated a single photon
emission computed tomography (SPECT)/CT imaging approach from pigs with limb ischemia to patients with
PAD and demonstrated that SPECT/CT perfusion imaging measures were repeatable in patients, detected
regional abnormalities in resting perfusion of the lower extremities, assessed perfusion defects that
corresponded with the level of future amputation, and quantified revascularization-induced regional
improvements in relative perfusion that were associated with risk of amputation after endovascular therapy. We
then developed and validated a dynamic positron emission tomography (PET) perfusion imaging approach
using fluorine-18 (18F)-sodium fluoride (NaF), a radionuclide traditionally used for molecular imaging of bone
and vascular microcalcification. Dynamic 18F-NaF PET imaging revealed utility for quantifying regional,
absolute measures of muscle perfusion (i.e., ml/min/100g) in pigs and PAD patients with limb ischemia that
coincided with microvascular remodeling in pig skeletal muscle and symptom severity in PAD patients. The
goal of this proposal is to leverage the novel PET perfusion imaging method developed in the prior funding
period to optimize regional evaluation of absolute measures of skeletal muscle perfusion in PAD patients
undergoing endovascular revascularization. To accomplish this goal, in Aim 1, we will validate dynamic 18F-
NaF PET perfusion imaging as an approach for monitoring ischemia-induced alterations in skeletal muscle
morphology and mitochondrial function using a newly developed porcine model of chronic limb-threatening
ischemia (CLTI). In Aim 2, we will establish a healthy clinical database for 18F-NaF PET perfusion measures
and compare these perfusion measures to standard indices of macro- and microvascular disease in patients
with PAD. In Aim 3, we will quantify absolute changes in regional calf muscle perfusion in response to
revascularization procedures in patients with PAD using dynamic PET imaging, and evaluate the relationship
between regional perfusion responses and clinical outcomes. These studies are designed to pre-clinically
validate the utility of dynamic PET perfusion imaging for evaluating adverse remodeling of skeletal muscle and
test the clinical efficacy of this method for monitoring regional responses to endovascular treatment and
predicting clinical outcomes.

Public health relevance
PROJECT NARRATIVE Lower extremity peripheral artery disease (PAD) is an atherosclerotic disease that is associated with increased levels of arterial calcification above and below the knee, which decreases blood flow and perfusion to the calves and feet, and increases risk of non-healing wounds, limb loss, and death. Our research team developed a novel PET/CT imaging paradigm that provides absolute measures of skeletal muscle perfusion within specific muscle groups and vascular territories of the lower extremities that correspond with adverse remodeling of skeletal muscle and PAD symptom severity. The overarching goal of the outlined projects is to pre-clincially test and clinically translate this functional imaging approach to comprehensively quantify regional abnormalities in lower extremity skeletal muscle perfusion in the setting of PAD, which could ultimately assist the vascular medicine community by improving non-invasive monitoring of PAD patients, evaluating the efficacy of targeted revascularization procedures, and predicting rates of major adverse limb events after therapeutic interventions.